Trial of Pirfenidone to Prevent Progression of Chronic Kidney Disease (TOPÃÂÃÂ¢ÃÂÃÂÃÂÃÂCKD)

Project Summary/Abstract
Chronic kidney disease (CKD) is a global health problem, affecting more than half of adults over 70 years of
age. Other than glycemic control in diabetes and use of angiotensin converting enzyme inhibitors, few specific
therapies are available. Fibrosis is a dominant factor in the development and progression of nearly all forms of
kidney diseases. Our group has led the development of non-invasive tests to evaluate the severity of fibrosis,
in the absence of an invasive kidney biopsy, and we have experience leading clinical trials in CKD. Pirfenidone
(Esbriet ®) is a first-in-class anti-fibrotic drug that is approved by the Food and Drug Administration (FDA) for
treatment of idiopathic pulmonary fibrosis (IPF). In large-scale, phase 3 studies in IPF patients, pirfenidone
showed substantial improvement in forced vital capacity, and significantly reduced the risk of death by 48%.
Pharmacokinetic studies and pilot studies show that pirfenidone is safe in the setting of CKD, and have defined
the dose of pirfenidone to maximize benefit and minimize side effects in CKD patients. Here, we propose a
two-site, double-blind, placebo-controlled, phase 2b trial of pirfenidone 1335 mg/day vs. matched placebo in
160 CKD patients. In our first aim, we will determine the effect of pirfenidone on changes in renal fibrosis
measured by diffusion-weighted magnetic resonance imaging (DW-MRI). In our second aim, we will determine
the effect of pirfenidone on changes in urine biomarkers that are known to reflect the severity of fibrosis on
biopsy, and are predictive of progressive loss of kidney function. Finally, prior anti-fibrotic trials in CKD patients
lowered serum creatinine in early phase studies, but failed to prevent CKD progression events in phase 3
trials. The lowering of serum creatinine proved to be due to fluid retention rather than improvements in kidney
function. To inform the most appropriate method to assess kidney function in a subsequent large- scale phase
3 trial, our 3rd Aim will determine whether the effect of pirfenidone on glomerular filtration rate (GFR) is similar
when using measured glomerular filtration rate (GFR) by iohexol compared with GFR estimates obtained from
serum creatinine or cystatin C. In the conduct of this trial, we will also obtain additional information about the
safety and tolerability of pirfenidone in CKD. If successful, this study will lead directly to a large-scale, phase 3
trial evaluating pirfenidone for prevention of CKD progression in moderate-to- severe CKD. This project is
ideally timed because of the combination of strong preliminary data, the FDA approval and widespread use of
pirfenidone for IPF, and the enormous unmet need for new CKD treatments.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT Chronic kidney disease (CKD) affects over half of the US population over the age of 70 years, and is characterized by extensive fibrosis in the kidney tissue. There are no specific therapies available to slow the progression of fibrosis in the kidney; however pirfenidone is a new anti-fibrotic drug approved by the FDA for lung disease and holds promise for CKD. This study will conduct a randomized clinical trial in CKD patients to determine if pirfenidone prevents progression of fibrosis in kidney disease over 1 year.